Continuation of The Collaborative Islet Transplantation Registry (CITR)

PROJECT SUMMARY
This application, in response to RFA-DK-21-013, describes a comprehensive Data and Statistical Coordinating
Center (DSCC) for the Collaborative Islet Transplant Registry (CITR) for 2022-2027. Continuing from 2017-2021
as the CITR-DSCC, Emmes continues to collaborate with the NIDDK Program Office, the Oversight Committee,
and the CITR investigators to support the established CITR Registry. The registry includes allogeneic and
autologous pancreatic islet transplantation, as well as any other beta cell replacement therapies that should be
followed for efficacy and safety in the resolution of refractory glycemic lability marked by severe hypoglycemic
episodes in persons with Type 1 diabetes or lacking pancreatic islets for any reason including therapeutic
pancreatectomy or any loss of islet cell function. For more details, please see the Specific Aims section.

Public health relevance
PROJECT NARRATIVE The continuation of CITR under Emmes’ professional, multi-disciplinary management will ensure collection of high quality data on allogeneic and autologous islet transplantation/beta cell replacement therapies, pancreatectomy-alone, and additional clinical treatment advances. Emmes works to assess health outcomes, which leads to high-impact manuscripts, addressing existing gaps of knowledge in the field for persons with type 1 diabetes and glycemic lability.